Injectable 3-month buprenorphine PLGA microparticle formulation

PROJECT SUMMARY
The objective of this Phase I study is to develop a 3-month delivery buprenorphine formulation for treating
opioid use disorder (OUD). Developing a long-acting injectable buprenorphine formulation is urgently
necessary for treating OUD. Currently, only two 1-month buprenorphine injectable formulations, Sublocade®
and Brixadi®, are approved by the U.S. Food and Drug Administration (FDA). Probuphine®, a 6-month
buprenorphine implant requiring surgical placement and removal, was discontinued in the U.S. in 2020.
Akina has cumulated over the last decade the knowledge and technology for making long-acting (1~6
months) injectable microparticle formulations based on biodegradable poly(lactide-co-glycolide) (PLGA). The
goal of this Phase I study is to develop a 3-month injectable buprenorphine PLGA microparticle formulation.
Specific Aim 1: To prepare and characterize a 3-month-acting injectable 300 mg buprenorphine formulation.
Specific Aim 2: To identify the key material and process factors that control the final formulation's attributes.
Development of a 3-month injectable buprenorphine microparticle formulation will be prepared using
Akina's technology and know-how. The innovation in this Phase I study is to utilize Akina's ability to select the
suitable PLGA polymers and solvents for controlling the buprenorphine release without the initial burst release.
There are diverse PLGA polymers differing in their lactide:glycolide (L:G) ratio, molecular weight, molecular
structure, and end-group. The innovation here is to select PLGA with the L:G ratio of 85:15, the molecular
weight of ≤100,000 Daltons, linear PLGA structure, and ester end-group based on our understanding of the
PLGA properties. It drastically reduces the design space over the trial-and-error approach.
The successful completion of the Phase I study will bring us into a promising Phase II study, in which a 3-
month formulation will be manufactured on a large scale (~300 g/batch) for in vivo buprenorphine release
studies using rats and dogs. Ultimately, Akina will introduce a 3-month injectable buprenorphine formulation
for clinical studies and the approval by the FDA.

Public health relevance
PROJECT NARRATIVE This project aims to develop an injectable 3-month buprenorphine PLGA microparticle formulation. Each formulation will contain 300 mg buprenorphine for sustained release to maintain the minimum therapeutic buprenorphine concentration of 0.7 ng/mL and above. The successful completion of Phase I study of manufacturing and characterization of the 3-month buprenorphine formulation will lead to scale-up manufacturing and in vivo pharmacokinetic studies in Phase II, leading to clinical studies.